Host immature myeloid cells in tumor suppressor or promoter roles of TGFbeta

As a new lab starting in 2009, we have been able to hire talented postdoc and graduate students working on this project. We have produced and bred mouse colonies in which TGFbeta R2 receptor is specifically deleted in tumor cells or host immature myeloid cells. We have observed significantly decreased tumor progression in myeloid TGFbeta R2 ko mice. We are currently investigating mechanisms which involves systemic immune response as well as tumor microenvironment. We are utilizing technical core resources and collaborating with several labs for this project.